Characterizing microvascular impairment in adults with elevated genetic risk for Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) represents a significant public health crisis that currently affects more than 6 million
Americans over the age of 65 years with a projected increase to 13.8 million by 2050. This anticipated increase
in the prevalence of AD emphasizes the need for a more complete understanding of disease etiology.
Possession of an APOE-ε4 allele is the strongest common genetic risk factor for developing late-onset AD.
APOE-ε4 also represents a significant risk factor for vascular disease. As a result, cognitive decline in ε4+
individuals may arise through classical AD pathways as well as independently through vascular-related
mechanisms. A high prevalence of white matter lesions in ε4+ individuals is thought to be an indicator of
microvascular impairment that results in tissue hypoxia and reduced oxygen availability to the brain. However,
microvascular physiological mechanisms that lead to reductions in cerebral oxygen availability in ε4+
individuals are not yet fully understood. Hypoperfusion has been thought to be the source of such hypoxia, and
cerebral blood flow (CBF) has been extensively investigated as a potential marker of hemodynamic impairment
in ε4+ adults. Meanwhile, CBF represents only one factor governing cerebral oxygen availability, and the
efficiency of oxygen extraction in the capillaries also plays an important role. The long-term goal of our work is
to elucidate physiological mechanisms through which APOE-ε4 contributes to microvascular impairment, white
matter lesion burden, and associated cognitive decline. We have previously proposed venous hyperintense
signal (VHS) on perfusion-weighted arterial spin labeling (ASL) magnetic resonance imaging (MRI) as a novel
marker of microvascular flow disturbances in older adults. More specifically, individuals with VHS exhibited a
higher white matter burden with older age than those without VHS, and this elevated lesion burden was related
to both a reduction in CBF and a decrease in oxygen extraction efficiency uniquely in those with VHS. Based
on these studies and preliminary data indicating that ε4+ individuals may exhibit unique physiology based on
the presence or absence of VHS, our central hypothesis is that reduced oxygen extraction efficiency and
impaired CBF regulation are important contributors to microvascular impairment in APOE-ε4. We will enroll a
well-characterized cohort of adults between 40-80 years of age who at varying risk for AD based on APOE
genotype to investigate the physiological mechanisms surrounding VHS and microvascular impairment in
APOE-ε4, including how these may vary by age, be related to AD biomarkers and cognitive function, and
differentially affect white matter lesion burden. Successful completion of this work may inform the development
of therapeutics aimed at mitigating microvascular contributions to cognitive decline in APOE pathology and
identify candidate hemodynamic biomarkers for stratification of at-risk individuals at an earlier age.

Public health relevance
PROJECT NARRATIVE Possession of an ε4 allele of the apolipoprotein E gene (APOE) is considered the strongest common genetic risk factor for developing late-onset Alzheimer’s disease (AD) that also represents a major risk factor for cerebrovascular disease. While classical AD pathophysiology has been well characterized in APOE-ε4, the impact of APOE genotype on microvascular physiology and white matter lesion burden remains incompletely understood. In this work, we propose to investigate a novel imaging marker of disturbed microvascular flow to study whether capillary level impairment in oxygen extraction efficiency and regulation of cerebral blood flow contribute to microvascular dysfunction in individuals with APOE-ε4 across the adult lifespan.